The Johns Hopkins Clinical Research Scholars in Women's Health (BIRCWH)

SF 424 R &R
PROJECT SUMMARY/ABSTRACT
The overarching goal of the Johns Hopkins BIRCWH program (JH-BIRCWH) is to develop highly qualified,
independent investigators who will conduct innovative and significant women's health and sex and gender
differences research. The program represents a successful and robust collaboration of the Johns Hopkins
Schools of Medicine, Nursing, and Public Health. In our first period of support, we recruited 10 Scholars, all
outstanding junior investigators from diverse disciplines, including 5 under-represented minorities. The success
of the program is illustrated by their success: 100% (5/5) JH-BIRCWH alumni secured new external federal
and/or foundation research funding. Because of JH-BIRCWH mentorship and career development, these
Scholars continue to develop as independent investigators and leaders in innovative, interdisciplinary research.
Scholars broaden their understanding through the lens of a life course perspective with particular attention to
research on the health needs of diverse and high-risk populations. During this next proposed period of support,
our JH-BIRCWH program is well positioned for sustained success. Consistent with the Office of Research on
Women's Health (ORWH) strategic plan (2019-2023), we will continue to recruit highly motivated junior faculty
scholars, with priority given to investigators from groups underrepresented in research. We will build on the
established foundation of our learner-centered and competency-based approach to interdisciplinary career
development. A critical resource for the JH-BIRCWH program is the cadre of highly experienced,
internationally recognized faculty who are active in research related to women's health or sex/gender
differences, and who are committed to supporting and sponsoring Scholars. The three core strength areas of
the JH-BIRCWH program are: 1) diseases specific to women (e.g. women's cancer and reproductive biology);
2) sex and gender differences in disease expression (e.g. immunology, neuroscience, cardiovascular and
genetics); and 3) social determinants of women's health and disparities (e.g. violence against women, trauma,
addictions and poverty). In this next proposed period of support, the JH-BIRCWH will annually support 3
scholars plus 2 additional scholars supported by institutional matching funds. Scholars will receive expert
mentoring from a multidisciplinary team along with funding, and access to institutional resources. They will be
well prepared to lead interdisciplinary teams to improve women's health by advancing our understanding of sex
and gender differences and health concerns unique to, more prevalent, or with differential consequences in
women.

Public health relevance
PROJECT NARRATIVE The Johns Hopkins BIRCWH program takes advantage of an extraordinary interdisciplinary academic environment to support the career development of promising junior scientists. Research will focus on diseases specific to women, sex /gender differences in disease expression, the social determinants of women's health, and sex /gender disparities. Scholars will develop into independent investigators and leaders in interdisciplinary women's health who improve clinical care for women and identify opportunities to more adequately address biological and social determinants of health.